Development of anti-PD-1-targeted chimeric antigen receptors and genetic circuits to deplete viral reservoirs in the nonhuman primate model of lentiviral infection

Project summary/abstract
Human immunodeficiency virus infects cells of the immune system and, if left untreated leads to the development
of acquired immunodeficiency syndrome and death. With the advent of antiretrovirals, HIV infection has turned
into a chronic infection. However, residual viral transcription is associated with increased risk for co-morbidities
in people with HIV infection. Programmed cell death protein 1 (PD-1) is an immune checkpoint protein expressed
on latently infected CD4 T cells and in particular T follicular helper (TFH) cells. TFH cells are located in the germinal
centers and are enriched in replication-competent human immune deficiency virus 1 (HIV) provirus in people
with HIV. My proposal builds upon the pre-clinical work I performed in non-human primates in which we
demonstrated that anti-PD1 chimeric antigen receptor T cells eliminated all detectable PD-1 expressing TFH cells;
the first time the elimination of this reservoir of HIV has been reported. Unfortunately, it also depleted memory
CD8+ T cells substantially, which led to accelerated disease progression. Provided we engineer higher safety
and specificity, the high potency of anti-PD1 CAR T cells suggest it offers promise for a functional HIV cure. The
goal of the proposed project is to define the genetic architecture of a safer and more specific second-generation
anti-PD-1 CAR. Aim 1 is divided in two sub aims that describe the development of first, a more specific anti-PD-
1 CAR by integrating its expression under the control of an additional TFH-specific synNotch receptor and second,
a safer CAR by adding an ON switch controlled by a small molecule inhibitor. These experiments will
demonstrate that a second-generation anti-PD-1 CAR is highly specific in depleting TFH cells and has the
potential to abrogate viral replication within B cell follicles more specifically, thereby providing foundational
knowledge to enable further studies towards an HIV cure. My career goals are to become an assistant professor
at a top-tier academic research institution. I aim to lead a research program that investigates cell therapies that
can contribute to end the HIV epidemic by providing a functional cure on an individual level, thereby decreasing
the number of HIV carriers over time. To this aim, I will receive training to use a NHP lentiviral infection model in
to develop next-generation HIV cure therapies, while expanding my knowledge of cell engineering. Dr. Lawrence
Corey (FHCC) will act as the primary mentor, who has substantial experience in HIV persistence, development
of antiviral agents and clinical trials, while supported by an Advisory Committee with expertise in gene and cell
therapies, and NHP models of HIV. I will present my work at international conferences and to my mentoring
committee. I will receive training in laboratory management/leadership, grant writing, negotiation, and mentoring
to help me lead a successful research team. FHCC has superb research facilities, professional development
resources and administrative support, which will provide the infrastructure to support my research and career
development as a mentored staff scientist and ultimately, my transition to independence.

Public health relevance
Project narrative This proposal develops the next generation of an anti-PD-1 chimeric antigen receptor T cell approach which cleared germinal centers of signs of T follicular helper cells and associated viral replication in the non-human primate model of lentiviral infection, albeit increasing extrafollicular viral replication due to depletion of PD-1+ CD8+ memory T cells. While exciting, additional safety features need to be implemented in this approach to make it clinically useful and it is arguably easier to engineer greater safety than to develop other approaches. By integrating more sophisticated genetic circuits and programmable control mechanisms into the current anti- PD-1 CAR platform, targeted depletion of TFH cells is improved, thereby providing foundational knowledge to enable further studies towards the role of TFH cell depletion for an HIV cure in the nonhuman primate model.